Discovery of Novel Inhibitors Targeting trans-Golgi Network Acidification in Pancreatic Cancer

PROJECT SUMMARY
Pancreatic ductal adenocarcinoma (PDAC) is projected to be the second leading cause of cancer-related
deaths in the United States by 2030. With a 5-year relative survival rate of just 10%, PDAC has the highest death
rate among the most common cancers, underscoring the urgent need for new therapeutic strategies that improve
clinical outcomes. Recent years have witnessed a growing appreciation of the role that metabolic reprogramming
plays in conferring survival advantages to PDAC cells, and the targeting of metabolic processes is considered a
promising area for the development of novel therapies. In contrast to normal cells, cancer cells favor glycolysis
for energy production, a phenomenon called the Warburg effect. As a glycolytic byproduct, transformed cells
produce an excessive amount of H+ ions. This cytosolic accumulation of H+ would be detrimental to cell fitness;
therefore, tumor cells have evolved mechanisms to achieve pH homeostasis. Using PDAC as a model system,
we discovered that cytosolic pH in cancer cells is regulated by organellar sequestration of H+ ions via
compartmental ion transport and that the trans-Golgi network (TGN) can act as a “sink” for cytosolic H+.
Importantly, normal cells do not employ this homeostatic mechanism. Using the NHE7 Na+/H+ antiporter, which
is primarily localized to the TGN, we have shown that targeting NHE7 causes acidification of the cytosol and
subsequent cell death in PDAC cells but not normal cells. We have further validated these findings in mouse
models of PDAC. Patient-centric data analyses show that TGN localized transporters are frequently
overexpressed in PDAC and their elevated expression is correlated with worse overall survival. To robustly
quantify pH in the lumen of the TGN, we have developed an innovative TGN-targeted pH biosensor assay, which
has been optimized for high-throughput (HT) screening of small molecule compound libraries to identify novel
TGN-selective acidification inhibitors. We have validated our TGN pH biosensor HT assay in a set of clinical trial
and approved drugs, as well as kinase inhibitors. To complement our HT screen, we have designed a cutting-
edge secondary and tertiary assay pipeline to further validate TGN-selective compounds. We hypothesize that
novel Golgi–specific small molecule inhibitors of organelle acidification will selectively prevent cancer cells from
achieving proper pH homeostasis, resulting in acidic cytosolic pH and cell death. In this grant we will: 1) perform
a large-scale HT screen to identify inhibitors of TGN acidification and confirm the hits, 2) validate the confirmed
hits using secondary assays and prioritize hit scaffolds, and 3) map compound effects to TGN components and
select and characterize final probe(s). Successful completion of this work will provide novel small molecule
chemical probes validated to interfere with TGN acidification and cause cancer-selective cell death, serving as
starting points to be further developed into safe and effective therapeutic agents for PDAC.

Public health relevance
PROJECT NARRATIVE Pancreatic ductal adenocarcinoma (PDAC) is in urgent need of therapeutic strategies that offer an improvement in clinical outcome and the targeting of cancer metabolism represents a promising approach in developing anti- cancer therapies. We have discovered that pH homeostasis is achieved in PDAC cells by employing the trans- Golgi network (TGN) as a “proton sink”, and we have developed a TGN pH biosensor assay for high-throughput (HT) screening of small molecules. The novel compounds that we identify will result in a loss of pH homeostasis and cancer-selective cell death, and may serve as chemical starting points to be further developed into safe and effective therapeutic agents for PDAC.